IVIS SpectrumCT

Project Summary
We present our proposal to acquire a Perkin Elmer IVIS SpectrumCT instrument that will be
installed in the IVIS core facility at the Albert Einstein College of Medicine. This new instrument
will replace a 12 year old imaging system that is at the end of its useful life. The replacement of
the old imaging system with the IVIS SpectrumCT instrument is a critical need for the Einstein
NIH funded investigators. IVIS been used effectively to monitor tumor or cellular migration and
to monitor dissemination of a variety of pathogens and is considered state of the art for these
type of studies. Because luciferase or fluorescence activity can be monitored without sacrificing
animals, longitudinal measurements can be made on individual mice over time minimizing the
number of animals required to obtain experimental data. NIH funded research projects at
Einstein that would benefit from this instrument are described in the proposal and include
projects in cancer biology and infectious disease pathogenesis. As noted, we require this
instrument to replace an IVIS imaging system that was acquired in 2010 and is the only IVIS
instrument in the core facility and the only functional IVIS imaging system at Einstein. Due to
the age of the current system several issues have arisen in the imaging camera and power
system indicating it is near the end of its useful duty cycle. In addition, the current software
updates are limited due to the age of the computer system in this instrument. Engineering
support and parts for this system are being increasing difficult to source and the vendor has
indicated that engineering support for this system will be eliminated. The Einstein IVIS core has
sufficient space to house the IVIS SpectrumCT instrument and renovations will not be required
to accommodate and install this instrument. In the last year, the Einstein IVIS Core laboratory
has assisted 40 different investigator laboratory groups with imaging using the IVIS system.
The Einstein IVS Core is also a critical support service for the Einstein Cancer Center and the
ERC-CFAR Einstein-Rockefeller-CUNY Center for AIDS research.

Public health relevance
Project narrative We present our proposal to acquire a Perkin Elmer IVIS SpectrumCT instrument that will be installed in the Einstein IVIS core facility. This technology is important for studies in cancer biology and infectious diseases and is a critical need for 40 different investigator laboratories at Einstein. Our current IVIS instrument is over 12 years old and service by the vendor will be discontinued. In addition, parts are also difficult to obtain due to age of the instrument. Overall, a replacement instrument is urgently needed to maintain reliable IVIS access for investigators.